Elucidating symptoms clusters in multiple sclerosis using patient reported outcomes and unsupervised machine learning

PROJECT SUMMARY
Multiple sclerosis (MS) is a chronic disease affecting 900,000 persons in the U.S, and it is a leading cause of
disability among young adults. Persons with MS (PwMS) experience wide-ranging symptoms across multiple domains,
alone or in combination, with varied severity. Some of these symptoms include optic nerve dysfunction and vision problems,
muscle weakness, bladder/bowel dysfunction, tremors, cognitive and emotional problems, and incoordination. The
objectives of the current application are to identify and characterize symptom patterns and clusters in PwMS, which are
aligned with PA-17-462, that states: “multiple sclerosis (is a) … model condition to advance (symptom) cluster research”.
Thus, our analytical framework will inform research in other poly-symptomatic conditions.
Stakeholders agree that the benefits of patient reported outcomes (PROs) and measures (PROMs) have not reached
their full potential for PwMS. PROs, which provide invaluable insight into the patients’ perspective, are increasingly used
in MS clinical trials and clinical practice as standard clinical measures fail to adequately measure impairment across domains
or lack sensitivity to detect subtle but meaningful change. Aligning with ongoing global MS initiatives, the current proposal
will focus on identifying and characterizing symptom patterns and clusters for PROs; which is also directly aligned with
NOT-OD-20-079, a Notice of Special Interest to stimulate “research to improve the interpretation of PROs at the individual
patient level for use in the clinical practice”. Furthermore, there is an additional incentive to maximize the use and
interpretation of PROs considering the shift to telemedicine service in response to the COVID-19 pandemic.
We have assembled a multi-disciplinary team of research scientists and clinical experts with access to two
unparalleled data resources (discovery and validation data sets), the 1st being the North American Research Committee on
Multiple Sclerosis (NARCOMS) Registry’s survey data for 21,558 PwMS spanning an average of 8.4 years (0.5 to 14 years)
and 269,468 biannual surveys, and the 2nd being the structured electronic health records (EHRs) for 8,687 PwMS see at the
Mellen Center for MS Treatment and Research (MCMS) at the Cleveland Clinic, spanning an average of 4 years (0.5-8.4
years) and 67,932 visits. In both resources, 11 MS-specific PROMs (MS-PROMs) were longitudinally captured including
measures of mobility, dexterity, vision, fatigue, cognition, bladder/bowel, sensory, spasticity, depression,
tremor/coordination, and pain. We propose the four complementary aims that will: 1. Characterize overall longitudinal
impairment patterns for each 11 MS-PROMs; 2. Identify distinct clusters of Pw MS with similar symptom patterns within
and across functional domains using machine learning approaches; 3. Develop new approaches to assess the strength of
causal inference and identify sources of model prediction errors in unsupervised machine learning; and 4. Create a dynamic
simulation dashboard for predicting MS phenotypes based on the findings of aims 1-3.
With these aims, we seek to advance MS phenotyping to facilitate improvements in research, clinical care, and
approaches to self-management. By focusing on PROMs, we will leverage the experience of PwMS which is independent
of their location (i.e. applications to rural residents) and ideal for telemedicine. We hope that our findings will advance care
and empower PwMS to engage in health decisions where personalized phenotypic characterization is necessary.

Public health relevance
PROJECT NARRATIVE There are 900,000 Americans living with multiple sclerosis (MS), who experience wide-ranging symptoms across multiple domains, alone or in combination, with varied severity. Key barriers to clinical management and future research include the absence of 1) knowledge regarding patterns in MS symptom development, and 2) knowledge of specific patient clusters who share similar symptom patterns and as a result may differentially respond to various interventions. In this project, we will use data analytic and machine learning techniques to characterize and identify symptom patterns/clusters within and across functional domains using MS-specific patient reported outcome measures, and build an adjunctive predictive dashboard informed by these findings that can assist clinicians and patients in disease management.